Structure and Specificity of Restriction-Modification (R-M) Systems

Project Summary/Abstract
This application is a request for a Diversity Supplement to train and support a talented PhD student, Mr.
Richard Quintana-Feliciano, to complement our parent grant (NIGMS R35-GM131780), titled “Structure and
specificity of restriction-modification (R-M) systems”. As a Hispanic first-generation student, and coming
from a low socioeconomic status, Richard has strived to excel at every step of his academic preparation,
and has shown the ability and motivation to contribute fundamentally to the goals of the parent grant. The
theme of the parent grant is the study of R-M systems that comprise the innate immune system in bacteria
and archaea. A new paradigm in the in R-M field is the co-option of orphan and R-M methyltransferases in
bacteria for epigenomic regulation of genes that are often associated with virulence factors. Richard
proposes to study DNA methyltransferases (BCAM09902 and BCAL3494) from B.cenocepacia that regulate
the bacterium’s biofilm formation or motility, as an extension of the parent grant. The research training is
designed to bring him to a stage where he can take a problem from its infancy to an atomic crystal structure,
with an understanding of the underlying thermodynamics and kinetics. The training plan has additional
important elements, including specific courses and directed reading, participation in seminars and meetings,
and an advisory committee to monitor and guide his progress. The expectation from this comprehensive
training plan is that he will be able to successfully defend an outstanding PhD thesis, publish papers in a top
tier journal(s), and also write a postdoctoral fellowship application for the next stage of his career in
developing as an independent academic investigator.

Public health relevance
This application is a request for a Diversity Supplement to train and support a talented URM student, Mr. Richard Quintana-Feliciano, to complement our parent grant (NIGMS R35-GM131780). Richard will undertake studies on two DNA methyltransferases from pathogenic B.cenocepacia that regulate the bacterium’s biofilm formation and motility. The studies will increase our knowledge of the structure and mechanism of these methyltransferase, and in the long term lead to possible new approaches to counter B.cenocepacia’s infectivity.